Novel Treatments for Modulation of Innate Immunity in Veteran Related Eye Diseases

Dry eye disease (DED) is a common condition that can cause discomfort and adversely affect visual quality and
quality of life. Many subtypes of DED are associated with ocular surface inflammation. Inflammation of the
ocular surface is mediated by both the innate and adaptive immune systems. Inflammation in DED can be
associated with ocular pain. Mixed DED (MDE) is characterized by decreased tear production (aqueous
deficient) and greater evaporation of the tear film (evaporative dry eye). MDE is often present in later stages
of DED. DED amongst Veterans is common, and can be associated with a more severe symptom burden than
civilians. Veterans are at risk for developing MDE due to high rates of multiple medication use and co-morbid
conditions, like glaucoma, post-traumatic stress disorder and depression. Current treatment options are
limited and primarily palliative. Great opportunity exists to improve the quality of life of Veterans by
developing novel treatments for inflammation in DED. An area of the immune system that has been
understudied and under-targeted by therapeutics in DED is the innate immune system. In particular Toll-like
receptor (TLR) signaling pathways may be over-active in DED. Histatin is a family of peptides found primarily
in saliva and is known to have significant wound healing and anti-bacterial properties. Little data exist on the
mechanisms of action of histatin peptides. We have found that histatin peptides can improve the health of the
ocular surface under experimental conditions that mimic DED. Our long term objective is to develop a new
class of DED therapeutics that target the innate immune system to reduce ocular surface inflammation. Our
central hypothesis is that histatin peptides can ameliorate the damaging effects of an overactive innate
immune signaling in DED. We will utilize a well vetted model of MDE in order to show the efficacy of histatin
peptides in treating DED. We will also undertake mechanistic studies to find the critical mediators of histatin
peptide effects on innate immune pathways in ocular epithelia. The proposed research is innovative as it is the
first study to investigate the use of histatin peptides as a treatment for innate immune over-activity in MDE.
We believe the results of these studies will yield significant progress in the development of new therapeutics
through the use of rigorous and well defined methods and metrics in clinically relevant translational models of
disease.

Public health relevance
Dry eye disease (DED) is a common condition that can cause discomfort, poor quality of vision and worsened quality of life. DED is more common among patients using multiple medications, including glaucoma medications, and in patients with depression, anxiety and post-traumatic stress disorder. DED is more common among older people and women. As Veterans age and there are increasing numbers of female Veterans, DED has become increasingly important for VA to address. Moreover, Veterans with DED have risk factors for worse outcomes and can have more severe symptoms than the general population. Many types of DED are associated with ocular surface inflammation and over-activity of the immune system, including components of the innate immune system. This project will demonstrate the utility of histatin peptides as a treatment for DED, and their ability to decrease damaging elements of the innate immune system. The results of this project will enhance healthcare for Veterans by creating a novel class of treatments for DED.